Winter Conference on Brain Research

This application is to request funds to support 15 young investigator travel awards for the annual Winter
Conference on Brain Research (WCBR 2025-2027). This conference is a popular forum for exploring new
developments in the neuroscience field usually with ~500 scientist attendees. There typically are over 80 panel
presentations and poster sessions (excluding the last afternoon) concluding with a special judged poster
session that includes the top-ranking poster submissions predominantly presented by young investigators.
Professional Development Workshops for graduate students, postdoctoral fellows, and junior faculty (initiated
in 2015) continue to maintain high attendance annually. Extended periods of time are set aside for breakout
groups, networking, diversity workshops, and scientific discussions. WCBR is an excellent opportunity for
junior investigators and trainees to interact with established investigators in a relaxed atmosphere. The
evaluations of recent conferences highlight the strong impact this meeting typically has on emerging as well as
established scientists. As the travel funds allocated for emerging scientists have not kept pace with the rising
costs of attending small, specialized meetings, we are requesting funding from other sources. We are hoping
that the results of our requests enable us to support a large number of junior investigators to participate in the
meeting. The conference traditionally takes place at a mountain venue in the western USA (rarely in Canada).
The 56th annual meeting will take place in Breckenridge, CO between 1/27/24-2/1/24 and the 57th meeting will
be in Lake Tahoe, CA between 1/24-1/29/25 (venues for future conferences will be decided at the 56th
meeting). For the 2024 WCBR meeting, the keynote speaker, who will also speak at a Brain Talk Town
Meeting open to the entire community, will be Gina Poe, PhD, Lorre Scholars Chair, Professor of Integrative
Biology and Physiology, Psychiatry and Biobehavioral Sciences at UCLA. There is an annual School Outreach
Program organized in collaboration with local middle and high school teachers in which up to 10 WCBR
scientists visit community schools. WCBR’s program is developed annually based on abstract submissions in
August each year. At WCBR 2024, 17 panels and one Pioneer session are specifically on abused drugs and
another 46 panels focus on reward-related topics or more broadly related to CNS plasticity. Thus, a large
proportion of the conference is highly relevant to understanding the neurobiological bases of substance use
disorders (SUDs) and alcohol use disorder (AUD) as well as neurological and neuropsychiatric disorders
consistent with NIDA’s and NIAAA’s missions. The fact that a large proportion of the participants are junior
investigators and a significant number are graduate students and postdocs ensures that this conference has
an impact on how future generations of neuroscientists view these issues.

Public health relevance
This application is to request funding for the annual Winter Conference on Brain Research. WCBR meetings highlight leading research in neuroscience, including a strong representation of the neurobiology of substance and alcohol use disorders, from preclinical, translational, and clinical perspectives that can lead to novel advances in our understanding of human brain diseases.